Role of Type I IFNs in Mucosal HIV-1 Immunity and Pathogenesis

ABSTRACT The gut is a major site for early HIV-1 infection and CD4+ T cell depletion, and a critical compartment for the antiviral action of the type I interferons (IFN) that include the 12 IFNα subtypes and IFNβ. However, the initial IFN response may be suboptimal, as transmitted/founder (TF) HIV-1 strains still manage to break through. Using next-generation sequencing, we reported that the IFNα subtypes expressed by plasmacytoid dendritic cells (pDCs) following HIV-1 exposure ex vivo had relatively weak antiviral activity. These weakly antiviral IFNα subtypes include IFNα2, the only IFNα subtype approved for clinical use, and IFNα1, a potential antagonist of type I IFN signaling. To date, in-depth studies on the regulation and biological properties of the IFNα subtypes and IFNβ in primary pDCs and gut cells has not yet been undertaken. Paradoxically, the type I IFNs were also linked to chronic immune activation, a strong predictor of HIV-1 disease progression. The phenotype is likely due to the immunomodulatory properties of the type I IFNs, but the exact mechanisms remain unclear. Of note, gut barrier dysfunction occurs early in HIV-1 infection, leading to the translocation of microbes into the lamina propria, resulting in immune activation. We reported that gram-negative commensal bacteria enriched in the gut mucosa of HIV-1-infected individuals enhanced HIV-1 replication and CD4+ T cell death ex vivo in the gut Lamina Propria Aggregate Culture (LPAC) model. Here, we hypothesize that the transition from a protective to a pathogenic role for type I IFNs may be driven by translocating enteric microbes. Microbial exposure may raise the threshold for the antiviral effects of type I IFNs to manifest and `license' immunomodulatory ISGs to promote myeloid (mDC) activation/trans-infection and CD4+ T cell infection/ apoptosis. These microbe-driven pathogenic effects of type I IFNs may be sustained during chronic infection. Interestingly, we observed that type I IFN responses during chronic HIV-1 infection are compartmentalized in vivo, with differentially enhanced IFN? versus IFN? in the blood versus the gut, respectively. To date, the cellular sources and mechanisms driving the elevated type I IFN signature in the gut remains unknown. We thus propose to investigate the role of type I IFNs in gut HIV-1 infection during the acute stage, at the onset of microbial translocation, and during the chronic stage. In Aim 1, we will evaluate the regulation, anti-HIV-1 activity and functional properties of the IFNα subtypes and IFNβ. In Aim 2, we will determine how type I IFNs modulate mDC activation and T cell function/survival in the context of HIV-1-associated gut dysbiosis and microbial translocation. In Aim 3, we will determine the source and triggers of abnormal type I IFN signature during chronic infection using gut tissues from uninfected, untreated HIV-1-infected and HIV-1-suppressed individuals. The results should provide urgently needed insights on how type I IFNs impact HIV-1 pathogenesis that may inform strategies to either harness these antiviral cytokines for curative strategies or block their immune effects to reduce chronic inflammation.

Public health relevance
PROJECT NARRATIVE Understanding the mechanism(s) underlying the protective and pathological role of IFNα in mucosal HIV-1 infection could direct the development of novel interferon-based antiviral therapies against HIV-1 infection.